Personalized End of Life Care in Safety-Net hospitals: Implementation of the 3 Wishes Project

Project Summary
Compassionate end-of-life (EOL) care is foundational to medicine, but providing patients and families in
safety-net hospitals (SNHs) with the sense that they are physically and emotionally supported during a
patient’s terminal hospitalization can be challenging. SNHs are public hospitals that primarily provide services
to low-income and uninsured patients on a minimal budget. Although high quality EOL care is an important
unmet need in SNHs, its provision is fraught with barriers and challenges. Language barriers, low health
literacy, and cultural differences can make it difficult for families in SNHs to perceive empathy and support
during the EOL. Deaths in the intensive care unit (ICU) for underserved families can be traumatic, and families
of patients who die in the ICU often suffer from depression and post-traumatic stress disorder. Palliative care
interventions are needed, but implementation is often resource-prohibitive.
The 3 Wishes Project (3WP) is a palliative care intervention that aims to achieve a dignified and
compassionate EOL experience by empowering the clinical team to elicit and fulfill small wishes for critically ill
patients who are dying in the ICU. Although the 3WP has been shown to improve a family’s experience of their
loved one’s EOL care, ease bereavement, and enhance clinician work satisfaction in academic centers, it has
not been implemented and evaluated in low-resource hospitals. We believe that this patient-centered and
clinician-partnered initiative can improve the EOL experience in SNHs, but that it must be adapted to the
contextual differences and needs of low-resource hospitals.
We propose to obtain and use stakeholder input to customize a multi-component 3WP Toolkit that will
facilitate 3WP implementation in SNHs. Using the tailored Toolkit, we will implement and evaluate the 3WP in
the three SNHs of the Los Angeles County Department of Health Services. We will conduct a pragmatic type 2
hybrid effectiveness-implementation study to evaluate the quality of EOL ICU care, bereaved families’
psychological symptoms, and clinician burnout as compared to usual care. We will use the Consolidated
Framework for Implementation Research (CFIR) and the RE-AIM (Reach, Effectiveness, Adoption,
Implementation, and Maintenance) framework to guide a mixed-methods evaluation of the 3WP
implementation in SNHs.
Our team of clinicians and scientists have collaborated previously and have expertise in EOL care,
implementation science, qualitative research, research in the safety-net system, and 3WP implementation. We
hypothesize that our novel effectiveness-implementation approach will demonstrate that the 3WP addresses
key gaps in palliative care in SNHs, which have historically had less ability to implement novel interventions.
The results of this study will provide a roadmap to implement interventions in SNHs and lay the foundation for
broader dissemination, adoption, and sustainment of the 3WP in diverse healthcare settings.

Public health relevance
Project Narrative Dignified and compassionate end-of-life (EOL) care is a cornerstone of high-quality, patient-centered care, but in safety-net hospitals EOL care is often overlooked, considered too late, or not at all. By eliciting and implementing final wishes for dying patients, the 3 Wishes Project (3WP) has demonstrated, in tertiary academic centers, that acts of compassion can improve the EOL experience and help families cope with loss. We propose to implement the 3WP in safety-net hospitals where there are less resources and more diverse, disadvantaged patient populations, and hypothesize that there will be similar positive effects on the EOL experience for patients, families, and clinicians.